PILOT STUDY OF TIPS STENT SHUNT FOR REFRACTORY ASCITES

To examine, prostectively the safety and efficacy of Transjugular Intrahepatic Portosystemic Stent Shunt for refractory ascites in cirrhotic patients and its effects on the pathophysiology of portal hypertension.